training - Autonomic Rare Diseases Clinical Research Consortium

TRAINING PROJECT SUMMARY (See instructions): The Training (Career Development) Component of the Autonomic RDCRC will develop an Autonomic Rare Disorders Clinical Research Consortium Scholars Program to train new investigators for clinical research in Rare Autonomic Disorders.Clinical disorders of the Autonomic Nervous System can have a devastating impact on the lives of the patients, which is compounded by the shortage of physicians who are knowledgeable about the pathophysiology and management of these disorders. This program will include a mentored research experience, a multi-institutional autonomic seminar series, a core didactic curriculum, and career development activities. The selection of the Autonomic RDCRC Scholars and their training will be a collaborative effort, involving all members of this Consortium. All of the Consortium investigators and their institutions have a long record of leadership in the field of Autonomic Disorders and have extensive experience in the mentoring or pre- and post-doctoral trainees.

Public health relevance
This program will provide trainees wilth the skills needed to lead multidisciplinary research teams in the pursuit of a better understanding of Rare Autonomic Disorders and will increase the number of knowledgeable physicians available to our patients with Rare Autonomic Disorders.